Care Assistant for Family Caregivers of Persons with Dementia During Out of the Home Activities

Abstract
Increases in life expectancy together with demographic trends have fueled a rapid increase in America’s
elderly population. As the number of older Americans has grown, so has the prevalence of aging-associated
diseases, including Alzheimer’s Disease (AD) and other related dementias (ADRD). An estimated 5.4 Million
Americans had AD in 2012, and that number is expected to double by 2030. It is estimated that most of these
patients (70%) live at home where they receive 75% of their care from informal caregivers who are unpaid
individuals such as family members, friends, and neighbors. The natural progression of the disease and its
burdensome behaviors cause significant stress for caregivers who frequently have close relationships to the
patient. Among caregivers of dementia patients, wandering behavior is one of the most stress-provoking
symptoms. Wandering is a common symptom that encompasses various walking behaviors that can result in
the patient becoming lost or disoriented leading to the risk of serious injury or death for the patient and stress
and reduced independence for the caregiver. Family caregivers often cannot leave patients home alone, and
instead must bring them on errands to large and complex indoor environments which present additional risk for
an AD patient to wander. Koronis Biomedical Technologies will develop a tracking solution that will give peace
of mind to caregivers in both stationary and mobile scenarios, alerting the caregiver to wandering behavior and
allowing them to quickly locate their loved one. It will consist of a monitoring system that features geo-fencing
and wireless tether modes for both indoor and outdoor use. Efficacy of the proposed system will be assessed
by family caregivers through a pilot clinical study, as well as through engineering evaluations.

Public health relevance
Narrative Informal and family caregivers provide three quarters of the care for America’s dementia population at great economic and emotional cost to themselves. These caregivers experience significant stress due to the burdensome behaviors associated with dementia. A significant source of stress is associated with a common disease behavior known as wandering or elopement. The proposed research seeks to develop a comprehensive caregiver tracking assistant device to reduce these burdens, and to facilitate greater caregiver independence.